Sunshine Education and Research Center

Overall Project Summary/Abstract
The Sunshine Education and Research Center at the University of South Florida (USF) in Tampa, Florida
started in 1997 to focus on interdisciplinary training of occupational safety and health professionals, training in
evidence-based practice and research, continuing education and outreach. The home base for the ERC is in
the College of Public Health and offers programs collaboratively with the USF Colleges Nursing and Arts and
Sciences, with Embry-Riddle Aeronautical University (ERAU) (Daytona Beach FL) and with the University of
Central Florida (UCF) (Orlando FL).
The Sunshine ERC is organized around center-wide activities, academic programs, outreach, and research
training. The center-wide activities include the day-to-day operations and the planning and evaluation effort. In
addition, interdisciplinary activities and the emerging issues fund are managed under the center-wide activities.
The Sunshine ERC offers academic programs in Occupational Health Nursing, Occupational Health
Psychology, and Health Safety and Environment (HSE) at USF plus Occupational Safety Management from
ERAU and Targeted Research Training at UCF. While we have phased out the industrial hygiene and
occupational medicine training programs, we propose to add the DrPH in occupational health, safety and
wellness and an MPH/Certificate program in social marketing.

Public health relevance
Project Narrative The Sunshine Education and Research Center focuses on interdisciplinary training of occupational safety and health professionals, training in evidence-based practice and research, continuing education and outreach. The home base for the ERC is in the University of South Florida College of Public Health and offers programs collaboratively with the USF Colleges Nursing and Arts and Sciences, with Embry-Riddle Aeronautical University (ERAU) (Daytona Beach FL) and with the University of Central Florida (UCF) (Orlando FL). The academic programs are Occupational Health Nursing, Occupational Health Psychology, and Health Safety and Environment (HSE) at USF plus Occupational Safety Management from ERAU and Targeted Research Training at UCF; while we have phased out the industrial hygiene and occupational medicine training programs, we propose to add the DrPH in occupational health, safety and wellness and an MPH/Certificate program in social marketing.